A fully automated tool for more accurate malignancy assessment in pulmonary nodules from chest CT

PROJECT SUMMARY
Each year in the United States, chest computed tomography (CT) identifies pulmonary nodules in about 1.6
million patients. Although >95% of these nodules are benign, a small fraction represent early-stage lung cancer,
the early detection of which is correlated with improved outcomes. Unfortunately, conclusive assessment of
ambiguous nodules often requires one or more invasive biopsies, which suffer from significant complication rates
and mortality. More specific, yet equally sensitive, non-invasive follow-up methods would avoid thousands of
complications or deaths each year. Computational tools using artificial intelligence (AI) can greatly improve the
diagnostic performance of CT by extracting subtle information that is missed even by expert radiologists. Despite
a proliferation of such AI tools with relatively high performance, they have struggled to transition into the clinic
because they have been implemented in ways that increase time burden for clinicians and non-reimbursable
costs for healthcare systems. In response to this need and the deficiencies of existing tools, IMVARIA Inc. will
adapt its fully automated, AI-powered digital biopsy (DigitalBx) tool for idiopathic pulmonary fibrosis (IPF)—the
first diagnostic AI tool for any lung disease authorized with both FDA Breakthrough Designation and novel AMA
CPT billing codes, and the only such tool in active clinical use—to the non-invasive analysis of nodules suspi-
cious of lung cancer from CT scans. We will provide clinicians with an end-to-end automated diagnostic solution
implemented as a secure cloud-based application fully reimbursable with CPT codes, alleviating the cost and
time burdens of other AI tools. We will also leverage our team's multidisciplinary expertise in AI, medical imaging,
and clinical pulmonology to achieve significant, clinically impactful improvements over existing non-invasive al-
ternatives. In Specific Aim 1 of this proposal, we will build, train, and test a new two-stage AI model to both
identify and classify pulmonary nodules in CT scans according to risk of malignancy (ROM), training the model
with ground-truth labels derived not from radiologist-labeled images (as is typical) but from broader clinical data
such as surgical pathology and two-year clinical follow-up outcomes. We will optimize the model using advanced
techniques such as Vision Transformers and 3D bounding spheres, with a target area under the receiver-oper-
ating characteristic curve (AUROC) of at least 0.95, which would be a substantial improvement over standard
CT or PET/CT assessment, while maintaining or improving sensitivity. In Specific Aim 2, we will bring the product
closer to FDA approval by conducting a validation study with the optimized and locked system in accordance
with CADe/CADx predicate pathway requirements. We will engage expert radiologists and pulmonologists from
Mayo Clinic in a reader study to assess ROM with and without the AI tool, with the goal of demonstrating a
statistically significant absolute improvement in AUROC of at least 5% with the AI tool. Upon achieving these
milestones, IMVARIA plans to seek Phase II SBIR funding for a larger-scale prospective validation study with
Mayo Clinic, ultimately obtaining FDA approval for DigitalBx in the diagnosis of suspicious pulmonary nodules.

Public health relevance
PROJECT NARRATIVE Chest computed tomography (CT) is a critical tool for the early detection and effective treatment of lung cancer, but often reveals ambiguous nodules that—while likely benign—require follow-up with invasive tissue biopsies that frequently cause additional complications and deaths. This project will develop a fully automated “digital biopsy” (DigitalBx) software tool to help clinicians accurately identify cancerous lung nodules in lung CT scans without additional time burdens or infrastructure costs. The ultimate goal is an FDA-approved software tool trained on objective clinical outcomes data that incorporates the most modern AI models and is easily adopted by both healthcare providers and payers, and will thus prevent thousands of complications and deaths each year by reducing invasive diagnostic procedures and misdiagnosis.